A Novel Multi-analyte Approach to Democratize Cancer Biobanking

PROJECT SUMMARY/ABSTRACT
The objective of this proposal is to establish a simplified and accessible procedure for multi-analyte simultaneous
extraction of DNA, RNA, and protein from tumor touch imprints that democratizes biobanking for low-resource
institutes. Traditional biobanking of fresh-frozen or FFPE tissue is resource-heavy and requires dedicated staff,
expertise, and storage facilities that may not be available at smaller institutes, which has the unintended impact
of disenfranchising lower socioeconomic populations. For example, only 1 in 10 specimens collected by the Can-
cer Disparities Research Network were from non-white patients. Thus, there is a need for improvements in pro-
curement technologies to address biobanking discrepancies. In addition, early detection and early treatment re-
sults in increasingly smaller tumor sizes obtained at surgery, which requires maximizing molecular recovery
from a single small sample. Our proposed approach will leverage tumor touch imprints on glass slides as a
method for biobanking, in combination with a multi-analyte molecular extraction protocol previously developed
for forensic applications. The technique enables simultaneous recovery of DNA, RNA, and protein from the same
small sample, including samples consisting of less than 10,000 cells. Our aims include optimization of the mo-
lecular extraction protocol from air dried touch imprints, and demonstration of non-inferiority relative to fresh-
frozen tissue and conventional molecular extraction methods. We will further optimize procedures to minimize
pre-analytical variables around storage time, storage method, and compatibility with fixation and cellular stain-
ing. Molecular yield and integrity will be measured and compared to fresh-frozen tissue. Recovered molecular
content will be assessed by DNA sequencing, RNA sequencing and protein analytics (Mass spectrometry and/or
protein arrays). If successful, our approach could provide a simplified method for multi-parametric analysis of
smaller sized tumors, including genomic analysis, gene expression profiling, and protein expression and activa-
tion, broadening the options for biomarker discovery as well as enabling correlative analysis of all analytes from
the same sample.

Public health relevance
PROJECT NARRATIVE Storage of tumor samples (“biobanking”), as traditionally performed, is an expensive and technically challenging method that is restrictive for smaller health institutes, particularly in lower socioeconomic areas. The infor- mation provided from biomarkers found in biobanked tissue can guide better treatment options for patients. We seek to develop a new lower cost approach for biobanking that will enable smaller, resource-poor institutes to store tumor tissue and analyze for biomarkers.